Investigating the role of intrahepatic plasma cells in the clearance of HCV infection: implications for rational vaccine design

PROJECT SUMMARY
The proposed work entitled “Investigating the role of intrahepatic plasma cells in the clearance of HCV infection:
implications for rational vaccine design” seeks to determine the mechanistic origins of liver-resident plasma cells
arising during acute hepaciviral infection. Understanding these cues would identify specific prerequisites of
interest to incorporate in vaccine regimens against hepatitis C virus (HCV). Given the ~2 million new infections
occurring annually worldwide, a prophylactic HCV vaccine would thus provide significant public health benefit.
We have recently demonstrated that an early generation of viral-specific B cells and antibodies is critical for
facilitating hepaciviral clearance in both humans and mice infected with hepatitis C virus (HCV) and an HCV-
related rodent hepacivirus (RHV), respectively. Given the essential nature of productive humoral responses in
this setting, it is critical to understand the mechanistic prerequisites enabling individuals to mount such a
response capable of derailing persistent infection as opposed to succumbing to chronicity in the absence of
timely antibody production. Seeking to determine the source of this immunoglobulin production, we identified a
marked anatomical skewing of IgG+ antibody-secreting cells (ASCs) within the liver during acute RHV infection,
while being virtually absent in peripheral blood, bone marrow, spleen, and lymph nodes. Distinguishing whether
this phenomenon represented a conserved immunological response to hepaciviral infection, we indeed observed
a robust expansion of antigen-specific ASCs within the liver as opposed to other tissue compartments in human
HCV infection as well. Serving to further validate the utility and biological relevance of the RHV infection model
for interrogating immunological facets of HCV infection, these preliminary findings naturally elicit investigation
into how and where these plasma cells originate. Our identification of intrahepatic germinal center B cells and
IgG+ tertiary lymphoid structures (TLSs) alongside the absence of appreciable ASC formation in SLOs during
acute RHV infection suggests that the liver may be capable of acting as a surrogate secondary lymphoid organ
during hepatotropic infection. Further, as we have previously shown that the window of acute infection where B
cells are essential for viral resolution is within the first two weeks of infection, the coinciding kinetic burst of
plasma cells arising within the liver around this time frame suggests that this intrahepatic humoral response is
integral for facilitating ultimate viral elimination. Given the critical nature of this response, the proposed studies
aim to characterize the mechanistic underpinnings of how and where plasma cell responses are generated
during hepatotropic infection. Either outcome, determining whether they follow traditional SLO priming and
inflammatory homing patterns or are primed locally within the liver parenchyma, should provide valuable insights
that are highly relevant to basic immunological paradigms. Furthermore, the proposed work should inform
strategies to enable functional recapitulation of these productive, essential responses in the rational design of
an efficacious vaccine against HCV.

Public health relevance
PROJECT NARRATIVE The proposed studies are designed to address the relationship between hepatotropic viral infection and the ensuing generation of intrahepatic humoral responses. How, when, and where plasma cells may arise locally within the liver will primarily be assessed via murine HCV-related rodent hepacivirus (RHV) infection. Identifying the precipitating cues driving these responses, in light of the critical role antibodies play in facilitating hepaciviral clearance, could provide novel insights regarding basic immunological principles of secondary and tertiary lymphoid organization while simultaneously informing rational HCV vaccine design.